Targeting allosteric scaffolding functions of Aurora kinase A in cancer

ABSTRACT
Neuroblastoma is the most common solid tumor in infants. About 25% of patients have high-risk
neuroblastoma, a devastating disease with poor prognosis and few treatment options. The primary driver of
high-risk neuroblastoma is the oncogene MYCN, a MYC-family transcription factor that has no druggable
pockets and has long eluded drug development efforts.
Recently, the protein kinase Aurora A (AurA) was shown to bind to the N-Myc protein in neuroblastoma
cells and interfere with its ubiquitination by the SCF ubiquitin ligase complex, preventing N-Myc from being
degraded by the proteosome. Blocking complex formation between AurA and N-Myc results in rapid N-Myc
degradation and cell death in neuroblastoma cell lines. The same AurA/N-Myc complex has now been shown
to drive neuroendocrine prostate cancer (NEPC), and AurA also forms a similar complex with the closely-
related c-Myc protein in liver cancer. These recent discoveries point to a new paradigm for targeting Myc-
family transcription factors in cancer using inhibitors that trigger structural changes in AurA that block
Myc protein binding and promote Myc degradation.
Our lab has recently shown that most existing AurA inhibitors, including the current clinical candidate
alisertib, do not have a strong enough allosteric effect on AurA to be effective at weakening N-Myc binding. In
agreement with this, alisertib has inconsistent effects on N-Myc levels in cell lines, and has not performed well
in ongoing clinical trials in neuroblastoma and NEPC. The weakness in our current understanding of how AurA
binds to c-Myc and N-Myc and how these interactions are affected by inhibitors represents a major impediment
to this therapeutic strategy for targeting Myc-driven cancers.
The goal of this project is to provide the missing molecular picture of the interactions between
AurA and Myc transcription factors and how they can be modulated by inhibitor binding. We plan to use
new experimental tools and approaches to define how the binding of c-Myc and N-Myc alters the conformation
(shape) and dynamics (protein motion) of AurA, and to delineate the specific structural changes an inhibitor
must trigger to efficiently destabilize these complexes. We will a) define the structure of the AurA/Myc
complexes at atomic resolution using x-ray crystallography, magnetic resonance spectroscopies and molecular
modeling, b) determine how these interactions alter AurA conformation and dynamics by tracking key structural
elements of the kinase in solution, c) correlate the effects of a large panel of kinase inhibitors on AurA
conformation with their ability to alter the binding affinities of N-Myc and c-Myc, and d) test the efficiency of the
strongest AurA allosteric modulators in a series of N-Myc- and c-Myc-dependent cancer cell lines including
neuroblastoma, NEPC and liver cancer cells. The insights will pave the way for the repurposing of existing
kinase inhibitors and the development of new inhibitors as a new treatment modality for Myc-driven cancers.

Public health relevance
NARRATIVE The protein kinase Aurora A binds to and stabilizes the oncogenic transcription factors c-Myc and N-Myc that are key drivers in a large subset of human cancers. This project aims to understand how Aurora A binds to c- Myc and N-Myc and how to disrupt these interactions with Aurora A inhibitors that trigger structural changes to block binding and promote c-Myc and N-Myc degradation in cancer.